2022 Oxygen Radicals GRC/GRS

Project Summary
This application seeks support for the 2022 Gordon Research Conference (GRC) on Oxygen Radicals:
Connecting the Chemistry of Oxygen Radicals to Medicine, taking place from January 30-February 4, 2022, and
preceded by the Gordon Research Seminar (GRS), organized by trainees for trainees, on January 29-30, 2022.
Both GRC and GRS will be held at the Ventura Beach Marriott in Ventura, California. We designed an exciting
program, bringing together leading scientists and scientists in training, representing diverse fields of research on
oxygen radicals, from basic chemistry to clinical applications and trials. The program focuses on advances in the
chemistry, analysis, biochemistry, and biology of oxygen radicals, covering redox signaling in cancer, aging and
age-related diseases, pulmonary diseases, neurological disorders, and cardiometabolic diseases. The program
includes two keynote lectures entitled The KEAP1-NRF2 regulatory system and its role in health and disease
and P62-NRF2 axis in the development of obesity-induced liver cancer, together with 31 additional invited
lectures, presented by senior scientists and rising stars in the area of oxygen radicals. We have reserved 12
slots for oral presentations, selected from submitted abstracts. The organizers will ensure that women and
underrepresented minority scientists will actively participate in the GRC, either through selection as invited
speakers or discussion leaders, through selection for speaker slots from submitted abstracts, or as presenters
of posters and presenters during the poster preview sessions. The poster preview sessions will be especially
important to give poster presenters a brief time to introduce the main content of their posters to the audience,
preparing all attendees for further vibrant exchange and discussions during the poster sessions. Among invited
speakers and discussion leaders, 46% are female, and all attendees of the GRC will have the opportunity to
address challenges women face in science and issues of diversity and inclusion during the Power Hour and
Representation by Women session. The GRC will create an environment of inclusion and belonging, specifically
integrating minorities and scientist in training into the community, for example through welcome tables. We will
ensure that during discussion sections, trainees will be given priority to ask the first questions. Invited speakers
will share cutting edge science and new discoveries the following sessions: Keynote session: Integrative cellular
stress responses: redox control of gene regulation; Chemistry and analysis of redox stress; Redox biochemistry
of proteins; Redox signaling in cancer: from mechanisms to therapy; Redox pathways in aging and age-related
diseases; Redox mechanisms in neurological diseases; Novel methods to study redox signaling; Oxidative stress
in infection, immunity and pulmonary diseases; Redox signaling in cardiometabolic diseases.

Public health relevance
Project Narrative This application seeks support for the 2022 Gordon Research Conference (GRC) on Oxygen Radicals: Connecting the Chemistry of Oxygen Radicals to Medicine, taking place from January 30-February 4, 2022, and preceded by the Gordon Research Seminar (GRS), organized by trainees for trainees, on January 29-30, 2022. Oxygen radicals are key to signaling pathways associated with the etiology of numerous diseases and biological aging, and understanding the intricacies of these pathways will be essential for the development of therapeutic approaches. The GRC and GRS will highlight advances in oxygen radical research, specifically focusing on cancer, aging, neurological disorders, pulmonary diseases, infection, and immunity, and cardiometabolic diseases.